Johns Hopkins Alzheimer's Disease Research Center

OVERALL – PROJECT SUMMARY/ ABSTRACT
The responsibilities of Alzheimer’s Disease Centers (ADC) have expanded considerably over the last few years and
now encompass not only basic and clinical research, but also training, community engagement, real-world
translation, and public health. The Johns Hopkins Alzheimer’s Disease Research Center (JHADRC) is an
integrated program of investigators whose overarching goal is to provide the infrastructure and resources to
support innovative research and training in Alzheimer’s disease and related dementias (ADRD), and to
contribute to city, state and national programs and collaborative activities with other ADCs. The particular
scientific focus of the JHADRC is on the earliest stages of Alzheimer’s disease (AD) and related disorders in
humans and in model systems, through characterizing the earliest clinical and pathophysiological processes,
and by identifying cellular and molecular events that contribute to the abnormalities in model systems that
capture aspects of the human disorders. Given the breadth of activities within our Center, many researchers
also focus efforts on improving care of patients in the symptomatic phases of AD. With this application, the
JHADRC is expanding the number of cores in the Center and will include 8 Cores and one component: (1) the
Administrative Core (Core A), (2) the Clinical Core (Core B), (3) the Data Management and Statistics Core
(Core C), (4) the Neuropathology Core (Core D), (5) the Outreach, Recruitment and Engagement Core (Core
E), (6) the Neuroimaging Core (Core F), (7) the Biofluid Biomarker Core (Core G), (8) the iPSC Core and (9)
the Research Education Component (REC). In this application we also include funds for 3 Developmental
Projects.

Public health relevance
OVERALL – PROJECT NARRATIVE The Johns Hopkins Alzheimer’s Disease Research Center is an integrated program aimed at finding improved treatments for individuals with Alzheimer disease and related disorders. Complimentary activities within the center include clinical and basic research studies that contribute significantly to national programs. In addition, the Center is dedicated to training the next generation of investigators and to reaching out to the community to improve understanding about these diseases.